CHOICES-TEEN: Efficacy of a Bundled Risk Reduction Intervention for Juvenile Justice Females

Project Summary/Abstract
Parent Grant: Adolescent young women involved with juvenile justice settings engage in
multiple health risk behaviors that place them at risk for HIV/STIs and pregnancy affected by
alcohol and marijuana. This study aims to test the efficacy of CHOICES-TEEN (CT) in reducing
the risks of substance-exposed pregnancy (SEP) and HIV/STIs among juvenile justice-involved
young women. Proposed Diversity Supplement: While a substantive portion of justice-
involved adolescent young women have been exposed to parental incarceration, and these
adolescents were at higher risk of substance use and sexual risk behaviors, extant interventions
for at-risk adolescents demonstrate limited effects on those with parental incarceration
experiences. This diversity supplement aims to determine the efficacy of CT for adolescent
young women with parental incarceration experiences by additional quantitative analyses of
data collected by the parent grant and collection and analysis of qualitative interview data from a
subsample with parental incarceration experiences following completion of the final 9-month
assessment. Specifically, Aim 1 will utilize multilevel logistic regression analyses and latent
growth curve modeling to determine the potential differential efficacy of CT in reducing the risks
of SEP and HIV/STIs among adolescent young women who have experienced parental
incarceration. In Aim 2, multilevel Bayesian structural equation modeling will be employed to
evaluate the mediating treatment effects of the mechanisms of action for CT by parental
incarceration. In Aim 3, qualitative interviews will be conducted with 20 adolescent young
women in the intervention arm to explore their lived experiences of parental incarceration that
may impact the efficacy and acceptability of CT and collect their suggestions for adaptations.
The proposed diversity supplement research serves as a natural extension of the parent grant
while offering a novel opportunity for a promising new investigator to initiate a new line of
prevention research focused on adolescents with parental incarceration experiences and
receive mentorship from a strong team of experienced researchers. This diversity supplement
will help the candidate gain skills and experience in intervention research, complex quantitative
analysis of clinical trial data, qualitative research, and manuscript preparation. Moreover, data
from this study will inform a K01 application on developing new or adapted interventions (such
as CT) for adolescents with parental incarceration experiences, with the long-term goal of
testing its efficacy in a larger R01 study. This diversity supplement will significantly contribute to
the candidate’s trajectory to becoming an independent NIH researcher.

Public health relevance
Project Narrative Parental incarceration is an increasingly prevalent life experience among adolescents in the U.S., especially with primarily ethnic minority young women involved in the juvenile justice system. Despite their high rates of substance use and risky sexual behaviors and the documented impact of parental incarceration on these behaviors, evidence-based interventions are lacking for this group of adolescent young women. This supplement study aims to better understand their unique health risk experiences related to parental incarceration and determine the efficacy of CHOICES-TEEN in reducing the risks of SEP and HIV/STIs for this high-risk, underserved adolescent population.